Women and HIV: Translation of Research into Practice; Bridging Early-Stage Researchers in Kenya to Independent Careers in HIV Research

Bridging Early-Stage Researchers in Kenya to Independent Careers in HIV Research
Abstract
The Kenya Medical Research Institute (KEMRI) and University of Washington (UW) program
entitled, Women and HIV: Translation of Research into Practice (WHIV) is requesting an
administrative supplement to bridge the critical gap for independent researchers beginning their
careers. The supplement will provide post-doctoral funding for two researchers in Kenya who
have or will have recently completed their PhDs. This supplement will contribute to the overall
goals of the parent grant and will continue to build research capacity to prevent new HIV infections
among women and adolescent girls in Kenya and sub-Saharan Africa and optimize care and
treatment for this high-risk, vulnerable population. To reduce incident infections and ensure long,
healthy lives for persons living with HIV, it is necessary to conduct locally relevant research that
addresses the know-do gap and informs national guidelines, clinical practice, and policy. The
WHIV training program’s primary goal is to build capacity at KEMRI and the Kenya Ministry of
Health (MOH) in implementation science focused on HIV, women, and adolescents, while creating
bridges to communities of adolescent girls and young women (AGYW), local health officials, and
other organizations responsible for healthcare practice and service delivery. For this supplement
we have solicited pre-applications from early-stage investigators at KEMRI and affiliated
institutions in Kenya. Among 8 applications, 4 met criteria and will be submitting full applications
to compete for a $35,000 award to support a one-year project. The WHIV Training Advisory
Committee and WHIV leadership team will select two proposals for funding based on the
candidate’s likelihood for success as an independent researcher and the project’s impact on HIV
prevention and care among women and AGYW in Kenya and research capacity building at KEMRI
and MOH. KEMRI’s longstanding commitment to conducting research that informs service
delivery and improves national health outcomes in Kenya provides a strong foundation for this
supplement application, which will be led by Dr. Elizabeth Bukusi. Dr. Bukusi is a Senior Principal
Clinical Research Scientist at KEMRI who trained as an obstetrician-gynecologist and
epidemiologist, earning her MPH and PhD at UW. She is a multiple PI on the parent training
program with Dr. Farquhar, UW Professor of Global Health, Medicine, and Epidemiology and
Interim Chair of the UW Department of Global Health. Using UW and KEMRI’s pool of experienced
mentors and well-established approaches to training, this program will establish greatly needed
implementation science research capacity at KEMRI and MOH and contribute to changing the
face of the HIV epidemic in Kenya.